Conferences on Emerging Statistical Issues in Biomedical Research

PROJECT SUMMARY This is a renewal of the R13 application to continue the very successful annual conference series on Emerging Statistical and Quantitative Issues in Genomic Research in Health Sciences, which has been hosted by the Program in Quantitative Genomics (PQG) at Harvard School of Public Health (HSPH) in the last five years and is open to the whole research community. Modern health sciences are evolving rapidly, driven in large part by the rapid advance of high- throughput biotechnology. This changing landscape has provided researchers in health sciences, especially in cancer and other chronic diseases, with rich opportunities for new discoveries using genetic information to better understand disease biology and etiology and interplay of genes and environment, and to enhance risk prediction and personalized medicine in patient care. While such an omics era presents many exciting research opportunities, the explosion of massive information about the human genome presents extraordinary challenges in data processing, integration, analysis and result interpretation. Traditional statistical and computational techniques cannot meet these new demands. There is a critical need to discuss emerging quantitative issues at the forefront of scientific exploration, and to promote development of innovative statistical and quantitative methods to deal with massive high- throughput genomic and 'omics data in basic, population and clinical sciences. In this renewal application, we propose to continue hosting this conference series, where each conference focuses on emerging quantitative research areas of most current genomic research interest and the particular focus will evolve over time. A key feature of the conference series is to provide a timely and interactive platform to engage cross-discipline senior and junior investigators, such as statistical genetists, computational biologists, genetic epidemiologists, molecular biologists, and clinical scientists in cancer and other chronic diseases to critique existing quantitative methods, discuss in-depth emerging statistical and quantitative issues, identify priorities for future research and disseminate results. The 2011 conference is entitled ''Emerging Statistical and Quantitative Issues in Genomic Medicine. The 2012 conference is on Beyond the 1000 Genomes Project: Sequencing, Complex Traits, and Population. The Conference series is cosponsored by HSPH PQG, the Department of Biostatistics of the HSPH and the Department of Biostatics and Computational Biology of the Dana Farber Cancer Institute. Serious efforts will continue to engage junior researchers, women and minorities in Conference activities.

Public health relevance
Project Narrative: The explosion of massive information about the human genome presents extraordinary challenges in data processing, integration, analysis and result interpretation. An annual conference on Emerging Statistical and Quantitative Issues in Genomic Research in Health Sciences is proposed to continue engaging cross-disciplinary quantitative and subject-matter researchers to critique existing quantitative methods, discuss in-depth emerging statistical and quantitative issues, identify priorities for future research and disseminate results in genomic research in health sciences. __SpecificAimsTextDelimiter__ SPECIFIC AIMS With the rapid advance of high-throughput technology, genomic sciences provide an exciting opportunity to redefine health and disease by taking into account vast amounts of new information concerning genes, gene expressions, proteins, and metabolites. This changing landscape has allowed researchers in health sciences, especially in cancer and other chronic diseases to use genetic information to better understand disease biology and etiology and interplay of genes and environment, and enhance risk prediction and personalized medicine in patient care. While such an "omics" era presents many exciting research opportunities, the explosion of massive information about the human genome presents extraordinary challenges in data processing, integration, analysis and result interpretation. Traditional statistical and computational techniques are difficult to meet these new demands. There is a critical need to discuss emerging quantitative issues at the forefront of scientific exploration, and to promote development of innovative quantitative methods to deal with massive high- throughput genomic and 'omics data in basic, population and clinical sciences. It is important to have a timely and interactive platform for quantitative scientists and subject-matter scientists to have cross-discipline talks, critique existing quantitative methods, engage in focused and in-depth discussions of emerging statistical and quantitative issues, identify priorities for future human genomic research in cancer and other chronic diseases. To respond to such a need, we propose to continue hosting the very successful annual Conferences on Emerging Statistical and Quantitative Issues in Genomic Research in Health Sciences, where each conference focuses on emerging quantitative research areas of most current research interest in human genomic and biomedical research, and the particular focus will evolve over time. Unlike traditional statistical conferences and subject matter conferences, a key feature of this conference series is its interdisciplinary nature, where quantitative and subject-matter scientists are engaged in discussing quantitative issues arising in cutting-edge genomic research in cancer and other chronic diseases. The Conference allows senior and junior statistical genetists, computational biologists, genetic epidemiologists, molecular biologists, and clinical scientists in cancer and other chronic diseases, to interact in a stimulating and interdisciplinary research environment, with plenty of time for discussions, debates and brainstorming. The Conference will continue to be hosted by the Program in Quantitative Genomics at the Harvard School of Public Health, and will be held at the Harvard Medical School's Joseph B. Martin Conference Center. The 2011 conference is entitled "Emerging Quantitative Issues in Genomic Medicine," covering three important topics: (a) Quantitative Issues in Personalized Medicines; (b) Reproducibility and Validation of Genomic Signatures in Translational Medicine; (c) Genetic Risk Prediction. The specific aims of the grant are: " To provide a timely and stimulating platform to engage quantitative and subject-matter scientists, such as statistical genetists, computational biologists, genetic epidemiologists, molecular biologists, and clinical scientists, in focused, interactive and in-depth discussions on emerging statistical and quantitative issues in cutting edge genomic research in health sciences, especially in cancer and other chronic diseases. " To enhance our understanding of important quantitative issues, and to introduce new concepts and breakthrough quantitative methods to push the boundaries of genomic research in basic, clinical and population sciences and translational medicine. " To stimulate discussions at the forefront of scientific exploration, to promote novel statistical and quantitative research to address important questions and needs in advancing genomic research in cancer and other chronic diseases. " To promote and foster interdisciplinary research and disseminate discussions and results to quantitative and subject-matter biomedical communities. " To promote the careers of young investigators, including students, postdoctoral fellows, and junior faculty members, especially underrepresented minorities and women, and to engage them in cutting edge research, by selecting them for platform short talks, encouraging them to present posters and facilitating interactions with more senior investigators.